Enhancing engineered T cell therapeutic efficacy for the treatment of pancreatic ductal adenocarcinoma

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDA) is a highly lethal malignancy with a 5-year overall survival of <10%.
Lethality is due to late diagnosis, early metastasis and therapeutic resistance. A hallmark characteristic of PDA
is the robust fibroinflammatory and suppressive tumor microenvironment that compresses blood vessels and
restricts drug access. This tumor microenvironment is also believed to interfere with immunotherapies, which are
transforming the standard of care for many other cancer indications. Tumor-antigen specific T cells are
responsible for mediating the therapeutic effects of immunotherapy. While much has been learned about
suppressive cells within the pancreatic tumor microenvironment, factors that impact the differentiation program
of antigen-specific T cells and their antitumor activity is markedly understudied in this disease. We created a
novel engineered T cell therapy that shows marked anti-tumor and anti-stromal activity in an aggressive and
difficult to treat genetically engineered PDA animal model that recapitulates many aspects of the human disease,
including response to immunotherapy. T cells engineered to express a tumor-reactive T cell receptor specific to
mesothelin, which is highly expressed by tumor cells yet poorly expressed by normal cells, is safe, destroys the
stroma, alters myeloid cell composition, induces objective responses, and significantly prolongs animal survival.
Notably, engineered T cells preferentially accumulate in primary tumors and metastasis, challenging the dogma
that PDA is immune privileged. Based on this efficacy, candidate T cell receptors specific to mesothelin for use
in patients have been identified leading to a Phase 1 clinical trial. However, despite engineered T cell persistence
and significant antitumor activity in vivo, a principle obstacle to cure is the progressive loss of engineered T cell
function within the suppressive pancreatic tumor microenvironment. While T cell functionality and differentiation
are well-studied in other cancer indications, little is understood regarding how the pancreatic tumor
microenvironment impacts tumor antigen-specific T cells. Here, we incorporate innovative tools we have
developed to identify mechanistically how engineered T cells mediate stromal remodeling, how the tumor adapts
and evades anti-tumor T cells, and then use this knowledge to develop a cutting edge engineered T cell therapy
for patient treatment with strategic advancements as compared to most cell engineering approaches. Our
Specific Aims are to: (1) Identify how engineered T cells mediate stromal remodeling, (2) Identify the contribution
of TCR affinity and the tumor microenvironment on T cell differentiation and functionality, and (3) Test the safety
and efficacy of a novel cell engineering approach for targeting solid tumors. Our studies will identify
characteristics of T cells and the tumor microenvironment that produce durable antitumor responses during
immunotherapy to create safe and durable clinical opportunities for pancreatic cancer patient treatment.

Public health relevance
PUBLIC HEALTH RELEVANCE Pancreatic cancer is a leading cause of cancer mortality with few effective therapies. This project will develop a novel immunotherapy that we show has pronounced therapeutic activity in preclinical animal models. We will uncover the mechanistic basis for the observed antitumor effects and create a novel immune therapy designed to change the standard of care for pancreatic cancer patient treatment.